Isochoric Pressure Based Preservation of Ovarian Tissue

ABSTRACT
This project combines and further develops our ice-free isochoric vitrification platform, multi-step/multi-thermic machine
perfusion, and next generation non-toxic cryopreservation cocktails to find a viable solution to the large public health
need for fertility preservation in children and young adults after different diseases and disease treatments. Such
technologies are urgently needed by 650,000 children and young adult cancer survivors in US, to help preserve fertility
and restore endocrine function post toxic treatments. The NIH has recognized this as a top priority, the fourth of NICHDs
Fertility and Infertility Branch’s SBIR priority research areas being focused on “Novel techniques for preservation of
gametes and whole ovary and testes.”
Using carefully optimized protocols and cryostasis cocktails, our team and others have successfully cryopreserved
multiple tissues in an ice-free vitreous “glassy” or “amorphous” state, allowing for indefinite storage. Unfortunately, these
advances in ice-free preservation have mostly not been successfully scaled beyond small-tissue and small-volume cell
suspensions due to the high cryoprotectant chemical concentrations, and rapid cooling/warming rates necessary for
current vitrification methods. However, our broader group together with Dr. Rubinsky at UC-Berkeley, have developed
a scalable and biocompatible isochoric (constant volume) cryopreservation paradigm for completely ice-free vitrification.
Building on the success of the Phase I feasibility study, this project will deliver: (i) an improved preservation and
banking of ovarian tissues strips via ice-free equilibrium isochoric vitrification (compared to current gold-standard slow-
freezing), (ii) comprehensive protocol for banking whole human ovaries with functional validation in human to mouse
xeno-transplants and validation in non-human primates with embryo development and eventually healthy offspring, and
(iii) clinically relevant prototype systems of isochoric vitrification, capable of banking whole ovaries (testes, or other
similar size tissues) for years until re-plantation. In addition, this project provides tools, equipment, solutions and
protocols with highly-translatable technology toward banking of whole vital organs, and other vascular grafts, addressing
widespread needs for breakthroughs in biopreservation – from improved biospecimen preservation to vital organ
banking and transplantation.
To meet these objectives, in four specific aims, we (i) with the help of thermodynamic profiling, further optimize the
composition of cryostasis solutions for isochoric vitrification with minimal pressures, (ii) refine the biocompatibility of the
cocktails and protocols using ovarian tissue strips, with human-to-mouse xenotransplants and human blood vessels
contractile functional assessment, (iii) scale to whole human ovary vitrification with multi-thermic machine perfusion and
clinical grade isochoric devices, and as a capstone, (iv) cryobank whole non-human primate ovaries with ovarian tissue
strips in vivo quality evaluation through minimally invasive autotransplantation, embryo development and eventual
healthy offspring. Success of these novel approaches, individually or in combination, can enable further breakthroughs
in oncofertility, biopreservation research, and clinical practice.

Public health relevance
NARRATIVE Technologies for cryobanking of ovarian, and testicular, tissues are urgently needed to protect the fertility of, often children, patients undergoing treatment for cancer, blood diseases such as sickle cell, autoimmune and metabolic disorders, immune deficiencies, and other diseases that eventually lead to gonadal failure. As the survivorship rates for cancer increase (85% 5-year survival rate in childhood cancers) and fertility preservation recently being recognized by the American Society of Clinical Oncology and the American Society of Reproductive Medicine as one of the most prominent survivorship issues for these patients, we have developed a novel approach to indefinitely bank functional ovaries, to protect fertility and restore endocrine function of these patients post toxic treatments. Our comprehensive approach, using our ice-free isochoric vitrification and machine perfusion platforms, (i) brings a totally new capabliity to the fields of prepuberty girl and boy and young woman infertility and oncofertility, that (ii) also can provide life-changing solutions for service members, and (iii) eventually can be horizontally translated to other complex tissue and vital organ preservation, with (iv) transformative effect in many areas of medicine, including transplantation, tissue engineering, trauma care and biomedical research.